A trauma-informed approach to improve engagement in HIV prevention and HIV care among transgender women

PROJECT SUMMARY/ABSTRACT
Dr. Glenda Baguso’s long-term goal is to be a high-impact, NIH-funded, independent investigator with
expertise working with marginalized communities at risk for HIV. Transgender (trans) women are
disproportionately burdened by HIV, yet have lower engagement in HIV prevention and HIV care compared
to other affected populations. To end the HIV epidemic, interventions are needed that address psychosocial
and structural factors that impact engagement in HIV care, such as trauma. The goal of the K23 is to address
trauma to improve HIV prevention and care engagement in community clinics that provide care to trans
women. This proposal uses three aims to achieve this goal. The first aim is to explore the relationship between
trauma, mental health, HIV prevention and care engagement, and the multi-level intersectional factors among
trans women using in-depth interviews with 20 trans women. The second aim is to examine barriers and
facilitators to implementing T-SBIRT, a trauma screener, brief intervention, and referral to treatment in
community clinics using in-depth interviews with 20 clinic stakeholders (e.g., leadership, health care providers,
staff). The third aim is to pilot test T-SBIRT with 50 trans women in a community clinic to assess
implementation outcomes. The implementation of T-SBIRT in a community clinic that provides care to trans
women will be guided by a modified intersectionality-enhanced Consolidated Framework for Implementation
Research. These specific aims will be achieved by the following training aims: 1) develop content expertise
on trauma stressors, T-SBIRT and mental health, 2) gain intersectional methodological expertise and
advanced skills in clinical trials and intervention development, and 3) develop knowledge and skills for
implementation science. The training aims are supported by Dr. Baguso’s mentoring team of experts in
trauma, mental health, intersectionality, and implementation science. With support from her mentors, UCSF,
and the department chair of the Department of Community Health Systems in the School of Nursing, Dr.
Baguso will successfully meet the training aims, complete the specific aims, and be fully equipped to launch
her NIH independent investigator career.

Public health relevance
PROJECT NARRATIVE Given that transgender women face high levels of trauma (e.g., events that result in harmful effects), clarifying the mechanisms by which traumatic events and the mental health sequelae impact HIV prevention and HIV care engagement is needed. This proposed study will explore trauma, mental health, and trans women’s engagement in HIV prevention and HIV care, implement an evidence-based trauma intervention, and explore implementation outcomes. Findings from this study will inform a larger scale study that will implement the trauma-informed intervention across multiple clinics to improve HIV prevention and HIV care for transgender women. .